Project 1: Maternal Prenatal Exposure to Environmental and Psychosocial Stressors and Long-term Risk of Depression

PROJECT SUMMARY/ABSTRACT--PROJECT 1
Depression is the leading cause of mental health-related morbidity worldwide, affecting approximately 300 million
people annually. Depression is nearly twice as prevalent among women than men and multiple individual and
psychosocial risk factors are associated with risk of depression. Hispanic women in the US have unique risk
factors for depression and other mental health disorders relative to non-Hispanic women including overcoming
stress associated with acculturation as well as lower awareness and utilization of mental health care services.
Traffic-related and ambient air pollutants are potentially modifiable environmental exposures that are known to
disproportionately impact health disparity populations and have increasingly been implicated in risk of
depression. Pregnancy is a period of dynamic biological and hormonal fluctuations designed to support fetal
development that may increase susceptibility to environmental insults and effects on later depression. Despite
growing evidence of the impact of prenatal air pollution on depressive symptoms in the first few months
postpartum, there have been no studies on whether exposures during this critical period may increase long-term
risk of maternal depression. Understanding biological mechanisms that mediate downstream effects of
environmental exposures may lead to improved treatment approaches and reductions in morbidity associated
with depression. As primary regulators of gene expression, epigenetic mechanisms, such as microRNA (miRNA),
may be important mediators of air pollution effects on depression. MiRNA regulate numerous cellular processes,
including neuroendocrine and inflammatory pathways important in depression pathophysiology. We will
investigate these mechanisms and the following specific aims in 500 women in the first four postpartum years in
the MADRES pregnancy cohort—an ongoing cohort of predominantly Hispanic, socioeconomically-
disadvantaged women in urban Los Angeles. We will (1) investigate the association of prenatal exposures to
traffic-related and regional air pollution with symptoms of maternal depression in the first four years postpartum
and examine whether these associations vary by prenatal psychosocial stressors and acculturation factors; (2)
evaluate whether there is a sustained response at 2 and 4 years postpartum between prenatal air pollution
exposures and neuroendocrine (cortisol, norepinephrine and epinephrine) and pro-inflammatory markers (IL-6
and CRP) known to be associated with depression; and (3) determine the role of neuroendocrine and
inflammatory-related miRNA in prenatal air pollution-related associations in maternal depression in the first four
years postpartum and test whether they mediate associations between prenatal air pollution and maternal
depression as well as examine the functional relevance of these miRNA. Results from this study may improve
policy and treatment approaches to reduce the burden of depression among health disparity populations.